Core D: Biostatistics Core

Summary
Core D aims to provide state of the art support for the biostatistics needs of the pre-clinical experiments proposed
in the P01 Grant. Core D will work with project investigators to create innovative feasible designs for the dose-
finding studies in canine clinical trials, and to create efficient study designs for the mechanistic animal studies.
We will execute efficient and robust statistical analyses, and work with the investigators to effectively present
their results for presentation. All of the analyses will be carried out using workflows and well-documented code,
thus ensuring the highest possible level of reproducibility for the findings relevant to the scientific questions of
interest. Secure cloud-based data storage systems will be used to share data, documents, protocols, and
analyses across all Projects and Cores, providing for real time coordination and review of experimental progress
and analyses. These tools have proven extremely valuable during the COVID-19 pandemic and will continue to
be used, assuring seamless collaboration with investigators situated in other institutions.

Public health relevance
PROJECT NARRATIVE The Biostatistics Core (Core D) provides comprehensive and expert analytic tools to support the mission of the P01 program project to rigorously test the hypothesis that Proton/Carbon/Electron Particle FLASH RT is superior to Standard Particle RT in protecting normal tissues while the two modalities are equipotent in controlling malignant growth. The core supports the public health mission of the NIH by supporting rigorous statistical design and analysis for all experiments conducted within the auspices of the Program Project, thus ensuring high levels of reproducibility.